Integrated University of Puerto Rico Clinical Trials Unit

This supplemental funding application aims to increase laboratory capacity to perform COVID-19 testing in the facility at the University of Puerto Rico Medical Sciences Campus (UPR-MSC) in the general population and individuals with risk factors.

Public health relevance
Expanded SARS-CoV-2 testing will allow the laboratory to identify individual infected in a more timely manner to minimize the impact of SARS-CoV-2 infection in the general population.